Computer Simulation of Electron and Proton Transfer

DESCRIPTION (provided by applicant): Proteins that control the transport of electrons, protons and ions underpin basic functions of living cells and are crucial to many life processes. For example, electron transfer (ET) and proton transport (PTR) combine to produce electrochemical gradients across membranes, which are then used to produce ATP. Similarly, ion channels play a vital role in neural signal transduction and other functions. Since mutations that disrupt the action of such proteins are associated with many diseases, these proteins present major targets for therapeutic intervention and play a central role in drug discovery efforts. However, further advances in rational drug development should be helped significantly by augmenting the progress in structural and biochemical studies by approaches that would provide the needed quantitative structure- function correlations. Thus, it is important to develop, refine and apply quantitative computer simulations tools for this purpose. Major progress in method development and validation, as well as pilot studies of key systems have placed this research effort in a pivotal position, where it can progress in providing quantitative structure function correlations of PTR, ion transport and ET. Thus, parallel advances in following directions are proposed: Aim 1 - Biological PTR - The method developed in the grant allows one to quantify the action of key proton-conducting systems. Thus, the proposed projects include: (i) Exploring the gating mechanism of the Cytochrome C oxidase (CcO), while focusing on well-defined proton channels. (ii) Our recent breakthrough in modeling the conversion of pH gradients to vectorial rotation in the F0-ATPase will be quantified, striving to gain a better understanding of the proton paths. (iii) The voltage activated PTR in Hv1 will be explored (iv) The progress in coarse grained (CG) modeling of the membrane potential will be exploited in interpreting the observed relationship between the effect of the membrane potential and the PT paths in CcO. (v) The study of the early PTR in bacteriorhodopsin will be extended, focusing on subsequent steps. Aim 2 - Biological control of ion transport - Our advances in CG modeling of the membrane potential will be exploited in further studies of the action of voltage-activated ion channels and the control of selectivity of ion channels. Aim3 - ET Processes - ET and ET/PT in CcO will be explored. Aim4 - Validations - Crucial validation of the different models will be conducted. 1

Public health relevance
PUBLIC HEALTH RELEVANCE: Charge transport proteins that control the transport of electrons, protons and ions play a crucial role in life processes. Mutations that disrupt the function of such systems are associated with major diseases, including neural disorders, diabetes, cardiac arrhythmia, cancer, osteoporosis and ulcers. The charge transfer proteins present major targets for therapeutic intervention and play a central role in drug discovery efforts. However, exploiting such possibilities requires the ability to convert structural informaton to a detailed understanding of the corresponding functions. We believe that computer modeling approaches can provide the needed structure-function correlations, and thus propose to continue to push the frontiers in modeling the actual function of proton transfer, electron transfe and ion transfer proteins. The proposed studies should provide a better understanding of the molecular origin of the different modes of biological charge transport. This should provide a major help in rational development of effective drugs that will accelerate the progress in fighting diseases associated with defective charge transport systems. 1 __SpecificAimsTextDelimiter__ Specific Aims Proteins that control and guide the transport of electrons, protons and ions underpin basic functions of living cells and are crucial to many life processes. This includes the generation of "chemical energy" by using electron transfer (ET) and proton transfer (ET) to produce electrochemical gradients across membranes, which are then used to produce ATP. Similarly, a vital role in neural signal transduction and other functions is played by ion channels. Since mutations that disrupt the action of such proteins are associated with many diseases, these proteins present major targets for therapeutic intervention and play a central role in drug discovery efforts. However, despite spectacular progress in the structural elucidation and biochemical characterization of the above systems, a quantitative understanding of the factors that control the operation of such systems is still needed. A better understanding of the function of such systems should help in the development of drugs against serious diseases. Thus, it is important to develop, refine and apply quantitative structure-function correlations using computer simulation approaches, and such studies are the central part of this proposal. During previous grant periods, we made a major progress in studying electron transfer (ET) in bacterial reaction centers (RCs). Subsequently we also placed more focus on exploring proton pumps and ion channels, where we validated and refined methods for multiscale modeling proton transport (PTR) on different levels of rigor and different time scales. Armed with these tools, we started to explore PTR processes in several biological systems, into account possible paths through ionizable residues of the protein and relevant water molecules and considering proton delocalization effects consistently. In the initial stage we made major progress in the study of aquaporin, gramicidin, cytochrome c oxidase (CcO ) and bacteriorhodopsin (bR). Subsequently, we exploited our new CG model in constructing a structure based model for the conversion of pH gradients to a vectroial rotation of the c ring of F0 ATPase. Furthermore, we succeeded recently to develop a powerful CG model of the complete electrode /electrolyte /membrane /membrane/protein system and to apply this model to the voltage activated Kv1.2 channel, capturing the energetics of the activation process. Our multiscale models put us in a position where we can progress in quantitative structure function correlations of PTR, Ion transport and ET. Overall, we will work in parallel on some of the most important unsolved problems in the field, and believe that the synergism from such an approach will be larger than just working on one of them. Thus we propose the following specific aims: Aim 1 - At this stage we can actually simulate the time dependence of PTR in proteins using realistic yet practical methods, where we can finally quantify the action of key proton-conducting systems. Thus we propose the following projects: (i) We will exploit our initial progress and continue to explore the gating mechanism of the redox-coupled CcO, putting more effort on well defined channels where the activation barriers and path for PTR are known with certainty . (ii) We will exploit our recent breakthrough in modeling the conversion of pH gradients to vectrial rotation in the F0-ATPase system and strive to gain a better understanding of the proton paths. (iii) We will explore voltage activated PTR in Hv1 (iv) We will continue in our study of the early PTR in bR and focus on the PTR in subsequent steps. (v) We will exploit our progress in CG modeling of the membrane potential to interpret the observed relationship between the effect of the membrane potentials and the paths of the PT steps in CcO. (vi) We will continue our studies of PTR in RCs, trying to reproduce changes in PTR pathways as a result of specific mutations. Aim 2 - We will exploit our recent advances in CG modeling of the membrane potential to further explore the action of voltage-activated ion channels as well as the control of selectivity of ion channels. Our proposed projects include: (i) Quantifying the interplay between the electrode potential and the protein/membrane landscape in the voltage activation process. (ii) Reproducing the gating current and the subsequent ion current and selectivity. Aim 3 - We will continue with crucial validation studies. This will be done by continuing our simulation studies of PTR in different systems for which the rate of PTR is known, where we will conduct much longer full EVB simulations and compare them to the simplified EVB with LD and MC simulations. Aim 4 - We will explore ET and coupled ET/PT in CcO.